The Human Pangenome Reference Consortium Coordination Center

PROJECT SUMMARY (Overall: Human Pangenome Coordination Center)
The human reference genome has been the cornerstone of human genetics and genomics research for over
twenty years. However, there is a broad consensus that no single reference sequence can fully represent the
spectrum of genomic diversity across global populations. Advances in sequencing technologies and a greater
appreciation for the importance of genetic diversity make improving the human reference sequence both timely
and practical. With advances in long-read sequencing technologies and computational methods, it is now
feasible to construct a human pangenome reference that captures and represents the full compendium of genetic
variation from a large collection of diverse genomes. We will extend the successful infrastructure developed by
the Human Pangenome Reference Consortium Coordination Center. In the next phase, we will significantly
improve the human pangenome reference by representing as much human genetic variation as needed to meet
disparate scientific and clinical applications, while engaging with international partners and the global research
community to provide a widely accessible and user friendly pangenomic resource and tool ecosystem. During
the second phase of the Human Pangenome Reference Consortium, our Coordination Center will: i) Continue
to maintain and improve the pangenome reference, including supporting the generation of additional diverse,
reference quality sequence assemblies; ii) Facilitate adoption of the pangenome reference by the broad research
and clinical genetics and genomics communities; iii) Foster the development and deployment of user-friendly
informatics tools for the pangenome; iv) Facilitate embedded ELSI research; and, v) Develop international
partnerships to ensure that the human pangenome reference engages with the populations it seeks to represent.

Public health relevance
PROJECT NARRATIVE (Overall: Human Pangenome Coordination Center) We will extend the successful infrastructure developed by the Human Pangenome Reference Consortium Coordination Center. Our team has extensive experience in managing large interdisciplinary research efforts, creating high-value community resources, running outreach activities including workshops, and managing NIH- funded consortia. We will coordinate among consortium elements, construct and validate pangenome representations, develop and support a pangenome tool ecosystem, engage user communities, and build the international Human Pangenome Project.